Task Order 5 - Environmental Polymorphisms Registry

The purpose of this severable task order is to maintain and support activities related to the maintenance and development of the Environmental Polymorphisms Registry (EPR) and EPR-related studies including questionnaires.